Guiding epilepsy surgery using network models and Stereo EEG

More than 1/3 of the world's 65 million people with epilepsy (~3.3 million in the U.S.) have seizures that cannot
be controlled by medications. Surgery and implanted devices are options for many, but their success depends
upon manually mapping epileptic networks, which is only possible for some patients, and poorly standardized.
When surgical targets are identified, there is currently no rigorous way to select the best surgical approach.
The overall aim of this proposal is to develop rigorous, standardized, quantitative methods to: (1) map
epileptic networks from imaging and Stereo EEG (SEEG), (2) pick the best region for resection, ablation or
neuromodulation for individual patients from their data and clinical hypotheses, and (3) to determine when focal
intervention is unlikely to succeed. These methods would have tremendous positive impact on clinical care.
Over the past four years we have made substantial progress towards these goals. We have developed: (1)
robust measures derived from subdural intracranial EEG (ECOG) that predict outcome from epilepsy surgery;
(2) personalized methods that localize epileptic networks and predict the impact of different interventions on
seizure control; (3) tools that predict the path of seizure spread from combined MRI and IEEG. We also have a
track record of openly sharing our methods, data, results and code on http: //ieeg.org, to accelerate research.
Based upon this work, we now innovate to solve 3 fundamental challenges to translating our work into
practice: (1) Guiding SEEG: We must develop new methods that account for the sparser sampling and
different philosophy of stereo EEG, which maps a network of connected brain regions and tests clinical
hypotheses about where seizures initiate and propagate; (2) Assessing sampling bias and missing
information: We will develop methods to determine if electrodes sample all key regions of the epileptic
network, to ensure we do not falsely localize due to missing information; (3) Validating in a larger population
across centers: In parallel to refining the above methods, we will validate and harmonize our analyses across
centers in a large number of patients to harden it for clinical use. In a novel model, we have engaged a group
of major surgical epilepsy centers to openly collaborate, standardize methods, aggregate data, and share all
algorithms, computer code, data and results on http: //ieeg.org. Our central hypothesis is that our quantitative
methods can be standardized across centers, predict outcome from personalized epilepsy surgery, and
ultimately be translated to improve clinical care.
This work is significant because it merges state of the art network neuroscience, engineering, neurology and
neurosurgery to make practical tools to improve and standardize patient care. It also establishes a
collaboration between 15 major epilepsy centers to standardize and share data. Finally, this project leverages
a thriving collaboration between experts in neurology, computational neuroscience, neurosurgery,
neuroimaging and bioengineering at Penn, with a strong track record of clinical translation.

Public health relevance
Project Narrative The proposed research is relevant to public health because developing new quantitative methods to target and test epilepsy surgery in computer models before doing these procedures in the operating room will improve patient outcomes and reduce surgery side effects and costs. In this research we are also working with 15 major epilepsy centers to standardize treatment. For these reasons the proposal is relevant to part of the NIH’s mission to foster fundamental, creative discoveries and innovative research strategies that will ultimately protect and improve human health for the United States’ 3.3 million people with epilepsy.